Cole Eye Institute Vision Science Training Program

ABSTRACT
This is a first renewal application for continued funding for the Cole Eye Institute Vision
Science Training Program (CEIVSTP) which is specifically designed to train pre-doctoral
Ph.D. students, medical students and post-doctoral fellows to become future leaders in
ophthalmology research. With T32 funds that provided training for 3 predoctoral students
and one post-doctoral fellow per year, we have supported 12 predoctoral students and 4
post-doctoral fellows over the past 4 years. One of our major long-term goals at the Cole
Eye Institute is to use CEIVSTP to limit and eventually merge the boundaries that now
separate clinical and basic research in ophthalmology. This training program is uniquely
positioned to achieve this goal for the following reasons: First, the trainers in this program
have been selected for their ability to perform outstanding ophthalmology research with
a translational focus on eye diseases. Second, the clinical mentors in the program are
highly successful clinicians with proven track records in research and a commitment to
the goals of the training program. Third, both a basic and clinician scientist will mentor
each trainee. Fourth, the housing of this program under one roof in the Cole Eye Institute
establishes a cohesive and comprehensive environment particularly suited to this
purpose. Fifth, the close interactions between medical students and Ph.D. students during
the research training, will promote communication between the clinical and basic areas
and foster scientific networks and collaborations that can continue into the future. The
strong didactic, research and clinical component of this program together with the novel
curriculum of the Molecular Medicine Ph.D. program will provide a solid foundation in
basic scientific principles in the context of human ocular biology and disease. This
proposal seeks continued funding for training outstanding pre-doctoral graduate
students, medical students working toward a masters level thesis and post-doctoral
fellows committed to ophthalmic research.

Public health relevance
PROJECT NARRATIVE A major goal of the Cole Eye Institute Vision Science Training Program is to train the future leaders in vision science research and to bridge the gap between basic science ophthalmic research and clinical ophthalmology.